Enhancing Undergraduate Preparation for Research in Aging and Neurologic Diseases

Project Summary/Abstract
In the decades ahead, demographic trends suggest that the sheer number of older
adults will increase, and they will make up a larger proportion of the overall population.
Many of these individuals will experience some type of neurological disease at some
point in their life. Consequently, we need an expanded cadre of scientists trained to
generate new knowledge about neurological conditions and aging. To address this
need, we will conduct an eight-week Summer Undergraduate Research Experience in
Aging and Neurologic Diseases at the Harvey A. Friedman Center for Aging at the
Institute for Public Health at Washington University. The program will 1) provide a
diverse group of undergraduate students with a closely mentored research laboratory
experience, combined with didactics and professional development sessions, and 2)
frame the research training in the context of aging and neurological disorders common
in later life. These goals address the need to nurture new researchers, diverse in their
backgrounds and experiences, to address the workforce shortage of scientists
investigating issues of an aging society.
Up to 10 undergraduate students each summer will be matched with an individual
faculty member whose research focuses on one of three neurological conditions (stroke,
Parkinson’s disease, or dementia) or who conducts research on interventions for
individuals with these conditions (e.g., home modifications, engagement in valued
activities). Students will also gather for weekly seminars that expose them to a
multidisciplinary perspective on aging, teach them research skills, and encourage their
professional growth and momentum toward further scholarship and training. With this
program we aim to engage trainees from diverse backgrounds and disciplines, which
reflects the diversity of the older adult population itself and the multidisciplinary
approach necessary to advance research on the prevention and treatment of neurologic
disorders.

Public health relevance
Project Narrative The Summer Undergraduate Research Experience in Aging and Neurologic Diseases at Washington University recruits undergraduate students with diverse backgrounds and disciplinary interests for an eight-week introduction to research on the prevention and treatment of neurologic disorders in older adults. Students join a laboratory focused on one of three neurological conditions (stroke, Parkinson’s disease, or dementia) for a closely mentored research experience. They also gather together for lectures, discussions, field trips, and professional development seminars to nurture their knowledge, skills, professional identity, and momentum as scholars.